Cell fate decisions in Merkel cell carcinoma initiation and maintenance

Merkel cell carcinoma (MCC) is a rare and aggressive neuroendocrine skin cancer that frequently carries an
integrated copy of Merkel cell polyomavirus (MCPyV) and expresses viral transforming antigens (TAgs) that
likely play a key role in tumorigenesis. MCC tumor cells also express transcripts detected in normal, post-
mitotic Merkel cells residing in skin, including a set of mRNAs encoding lineage-specific transcription factors
implicated in neuroendocrine cell fate. Work from our lab and others established that MCPyV small T antigen
(sTAg), +/- truncated large T antigen (tLTAg), is sufficient to drive transformation in vivo, but MCC-like
tumors were not detected in any of these models despite TAg targeting to various potential tumor progenitor.
The lack of a viable mouse model of MCC has been a major impediment to progress in this field.
Normal Merkel cells arise from epidermal progenitors in specialized cellular compartments called touch
domes, but the cell of origin of MCC is unknown. In an effort to override the apparent resistance of multiple
cell types to MCPyV TAg-driven MCC development in genetically-engineered mice, we generated mice co-
expressing the Merkel cell transcription factor Atoh1, together with MCPyV TAgs, in epidermal keratinocytes.
These mice developed small collections of proliferating MCC-like tumor cells, and when coupled with deletion
of one copy of p53, yielded gross tumors strikingly similar to human MCCs based on multiple criteria. Given
the pivotal role of Atoh1 in MCC tumorigenesis we performed complementary loss-of-function studies, and
discovered that Atoh1 knock-down converts human MCC cells from their typical neuroendocrine phenotype
and growth in suspension, to cells with adherent growth, loss of neuroendocrine markers, and more aggressive
behavior in vivo.
We thus hypothesize that Atoh1 and other transcription factors governing Merkel cell fate play a pivotal role
in MCC pathogenesis as well as maintenance of the neuroendocrine tumor phenotype. We propose the
following aims to test this hypothesis. 1) Generate and characterize MCC-like tumors driven by MCPyV TAg
expression targeted to candidate MCC progenitor cells. 2) Determine whether MCPyV TAg expression is
required for mouse MCC maintenance. 3) Examine the role of Merkel cell lineage transcription factors in
governing neuroendocrine cell fate and biological behavior of human MCC cell lines. These studies will yield
new insights into the molecular basis of MCC and validate a much-needed mouse model of MCC.

Public health relevance
Merkel cell carcinoma (MCC) is a rare and aggressive skin cancer caused by a virus. Because we do not know where MCCs arise, it has not been possible to create a mouse model of this cancer. In this grant, we propose to combine viral oncogenes, together with factors that produce Merkel cells, to generate and study MCC tumors in genetically-engineered mice.